Biological drivers of sex differences in frontotemporal dementia

ABSTRACT
Dementia prevalence and disease course differs by sex. Yet, despite being the leading cause of young onset
dementia, very little is known about sex differences in frontotemporal dementia (FTD). Our accumulating data
suggest females with FTD show patterns of “cognitive resilience” consistent with delayed symptom
manifestation, despite higher neurodegenerative burden. We hypothesize that female-specific biology drives
the unique clinical course of women suffering from FTD. Our overarching goal is to deeply characterize
understudied female biology to unlock new insights into FTD pathophysiology, precision treatments, and novel
dementia risk and resilience targets for all brains. To do so, our proposal will leverage two deeply phenotyped,
longitudinally-followed local and international cohorts of genetic and sporadic forms of FTD and healthy
controls (n=1095). We will be the first comprehensive evaluation of biological sex differences in FTD. Our Aims
will: 1) Prospectively assay longitudinal sex hormone levels in plasma (e.g.,17𝛽-estradiol, testosterone,
progesterone), 2) Identify sex-specific proteomic signatures of FTD from cerebrospinal fluid and plasma, 3)
Collect a new female reproductive health history measure (e.g., age of menopause, pregnancies), and 4)
Develop disease progression models that incorporate sex-specific factors to precisely prognosticate FTD
trajectories in males and females. This proposal contributes to a high priority, underserved scientific area. For
instance, among neuroimaging papers published since the 1990s, <0.5% consider factors specific to the
female body. This knowledge gap creates treatment inequities as evidenced by the currently available therapy
for Alzheimer’s disease (Lecanemab), which shows less than half the efficacy in females compared to males.
Our proposal will therefore address a major health disparity, advance precision approaches to FTD before
treatment inequities arise, and leverage overlooked female biology to discover new insights into dementia
prevention targets relevant for all brains.

Public health relevance
PROJECT NARRATIVE Despite clear importance for dementia risk and manifestation, very little is known about sex differences in frontotemporal dementia (FTD). We will be the first study to comprehensively evaluate how biological sex contributes to FTD, including sex hormones, unbiased proteomics, reproductive histories, and development of sex-specific disease progression models. Our proposal is positioned to gain fundamental insights into FTD pathophysiology and leverage understudied female biology to discover new risk and resilience targets relevant for all brains.